The roles of Anaplasma phagocytophilum surface proteins in cellular invasion

DESCRIPTION (provided by applicant): Anaplasma phagocytophilum is an obligate intracellular bacterium and rickettsial pathogen that invades neutrophils and endothelial cells to cause the emerging and potentially fatal infection, human granulocytic anaplasmosis (HGA). A. phagocytophilum converts its host neutrophil into a Trojan horse that facilitates pathogen replication and dissemination. The bacterium down-regulates the neutrophil antimicrobial response, raising susceptibility to opportunistic infections. Blocking A. phagocytophilum infection of neutrophils would prevent the stage of HGA associated with pathogen dissemination and increased risk of opportunistic infections. A. phagocytophilum infects microvascular endothelial cells of heart and liver. Endothelial cells are also implicated as the initial cell type that A. phagocytophilum infects following inoculation via tick feeding. Infected endothelial cells are capable of transferring the bacterium to neutrophils. Abrogating A. phagocytophilum invasion of endothelial cells would potentially prevent infection of major organs and initial establishment of infection. The overall goal of this project is to functionally characterize A. phagocytophilum oute membrane proteins that facilitate infection. We identified outer membrane protein A (OmpA) and Asp14 (14-kDa Ap surface protein) as the first two A. phagocytophilum proteins that are critical for invasion of myeloid and endothelial cells. Targeting OmpA and Asp14 nearly abolishes A. phagocytophilum infection of host cells. In Aim 1, we will identify the OmpA and Asp14 domains that mediate A. phagocytophilum uptake and determine if either protein is sufficient for invasion. In Aim 2, we will identify the host cell receptors of OmpA and Asp14. In Aim 3, we will directly assess the relevance of OmpA and Asp14 to infectivity using novel transgenic A. phagocytophilum organisms that can be induced to express antisense RNA against ompA or asp14 to knock down OmpA or Asp14 expression. This research will provide a robust understanding of A. phagocytophilum cellular invasion and identify the first two invasin-receptor pairs for any Anaplasmataceae pathogen. As OmpA and Asp14 are conserved among several rickettsial pathogens, our work will provide direction for vaccine development against a subset of bacteria that causes HGA and other debilitating diseases. Lastly, our work will yield a valuable tool for assessing gene function in obligate intracellular bacteria.

Public health relevance
PUBLIC HEALTH RELEVANCE: Human granulocytic anaplasmosis (HGA) is an emerging, potentially fatal disease caused by a bacterium that invades blood vessel endothelial cells and white blood cells called neutrophils. We have identified two bacterial factors that are critical fo infection of both host cell types. The proposed research will determine how the two bacterial factors mediate infection. Doing so will aid the design of novel strategies for preventing HGA.